U-RISE at CSUSB

Summary
The Undergraduate Research Training Initiative for Student Enhancement (U-RISE) program will be an
institutional-wide effort involving students and faculty in Biology, Chemistry, Psychology and other relevant
departments. The mission and long-term goal of the California State University, San Bernardino (CSUSB) U-
RISE Program is to increase the diversity of the biomedical research workforce through the mentoring and
training of undergraduate students. The U-RISE program will accomplish this goal by: 1) providing support to
keep UR students in STEM majors, and 2) motivating students to pursue careers in biomedical research. In order
to keep students in STEM majors, we will provide access to tutors and supplemental instruction for gateway
science courses, as well as faculty and peer mentoring. To enhance motivation to pursue biomedical research
careers, students will engage in authentic research experiences on the CSUSB campus and at research-
intensive universities. CSUSB is well-positioned to accomplish the goal of increasing the diversity of the
biomedical workforce because it has a diverse student body, a strong institutional commitment to student
success, and a tradition of faculty mentors who actively involve undergraduate students in their research.

Public health relevance
Narrative The future of the nation's biomedical research workforce depends on the continued development of well- trained undergraduates who seek Ph.D. degrees in the biomedical and behavioral sciences. The next generation of researchers will increasingly be made up of underrepresented students who historically have not pursued such career goals. This project seeks to attract and prepare students from a diverse student body to meet this national need.